MegaTrans – human transporter machine learning models

Summary
Being able to predict interactions with important human transporters would be of value to new drug design to
avoid compounds that interact with them and cause undesirable side effects. Conversely, some drug transporters
can be used for targeting molecules to specific organs and this may have considerable utility. Understanding the
interactions of novel drugs, natural products and environmental toxicants and their interactions with an array of
such transporters is, therefore, important for several industries, as well as from a regulatory perspective (e.g.
FDA, EPA and EMA). Being able to predict such interactions in a fast and reliable manner effectively requires
using computational approaches and learning from in vitro data, the latter a resource that is rapidly growing.
Over the past 20 years, we have been at the forefront of applying different machine learning approaches to
modeling drug transporters and, in many cases, developing datasets for transporters for which there was scant
available data. We now propose doing this for several transporters that may be important for drug discovery. In
Phase I we focused on OATP1B1 (SLCO1B1), which is an uptake transporter largely restricted to the sinusoidal
aspect of hepatocytes where it mediates transport of a variety of structurally unrelated compounds, including
members of several clinically important drug families (incl. statins, sartans and angiotensin converting enzyme
(ACE) inhibitors). We tested 476 drugs against one substrate in vitro. We then curated these data and built
machine learning models using multiple machine learning methods as well as model evaluation metrics. This
enabled us to develop models for integration in a web-based software tool called MegaTrans® that enables the
user to input their own compound structures and generate predictions for interactions with transporter/s of
interest, as well as visualize the similarity to the training set of each model using several different visualization
methods. In addition, during Phase I we also performed preliminary data curation, model building and validation
for two equilibrative nucleoside transporters (ENTs), ENT1 and ENT2, that are present at the blood testes barrier
(BTB), where they can facilitate drug disposition (e.g. for antivirals, thereby potentially eliminating a sanctuary
site for viruses detectable in semen). We generated Bayesian and pharmacophore models and used these to
predict numerous compounds that were then tested in vitro against ENTs. We used these ENT models to predict
(i) the antivirals used in treating COVID-19, remdesivir and molnupiravir, inhibit ENT activity, and that (ii)
remdesivir is an ENT substrate, as well as validating these predictions. In Phase II we plan on building on the
foundation of Phase I and propose greatly expanding the ENT1 and ENT2 models through in vitro testing (at the
University of Arizona) of >2000 approved drugs, natural products, and environmental toxicants as inhibitors of
ENT transport. We will use these data to build and validate machine learning models using several algorithms,
at Collaborations Pharmaceuticals, Inc. We will also test these models using external validation with additional
molecules from vendor libraries and drug collections that are not in the model. In this process we will also build
out the capabilities of MegaTransÒ to use 3D pharmacophore descriptors to incorporate molecular shape
features and allow 3D searches. The return on investment of such a commercial tool would be that it could assist
in the design and selection of more favorable compounds by avoiding transporters of interest (or, conversely,
allow the targeting of specific transporters to increase uptake into organs). It could also identify compounds that
are already approved that might present a drug-interaction risk. Predicting such behavior seen in vivo is ideal
and will lead to the prioritization of compounds to test in vitro for potential drug-drug interactions. In summary,
we propose generating large training sets for ENT1 and ENT2 transporters that we will use to generate an array
of validated machine learning models of interest to drug discovery (with specific interest for those generating
antivirals). MegaTransÒ will be a commercial product available for licensing by pharmaceutical, consumer
product, agrochemical and regulatory groups, as well as fee-for-service consulting provided by Collaborations
Pharmaceuticals, Inc.

Public health relevance
Project Narrative The objective of “MegaTrans®” is to develop a new computational system and tools for integrating human transporter data into drug discovery pipelines, as well as enabling its analysis and visualization. This will then enable improved computational tool development for in vitro to in vivo extrapolation of xenobiotic exposures across a range of assay types. It will also assist with developing computational tools for quantitatively modeling drug-drug interactions of xenobiotics. We will generate data for transporters which currently have a paucity of data in the public domain, use validated machine learning algorithms, access the latest curated datasets and develop a user-intuitive interface and visualization system to enable predictions. MegaTrans® will be developed as commercial quality software and then commercialized by licensing to companies, as well as used in fee-for- service consulting projects.